EFFECTS OF ANXIOLYTIC THERAPY ON NEURAL OUTFLOW AND MENTAL STRESS

Effects of alprazolam on plasma norepinephrine levels and central sympathetic neural outflow in humans during physical and mental stress.